Multiscale Network Modeling of Hemodynamically-Driven Vascular Adaptation

DESCRIPTION (provided by applicant): Heart disease, strokes, and limb loss continue to lead mortality and morbidity. Despite advances in surgical and endovascular treatments, long-term success of these interventions remains limited. Researchers have applied a variety of approaches to modify neointimal hyperplasia and vascular remodeling in an effort to improve the outcomes; however, attempts have been largely ineffective due to incomplete understanding of the specific cause/effect links through which hemodynamic factors, biochemical mediators, and cellular effectors lead to an occlusive vascular phenotype after intervention. Prior research has focused almost exclusively on either the static isolated physical or biologic components. For instance, we confirmed that wall shear stress stands as a key regulator of vascular architecture. In parallel, we established that temporally distinct vessel wall inflammatory events (mediated by blood monocytes) predict long-term morphology. However, completely lacking is an understanding of the dynamic interplay between physical forces and cellular inflammatory elements that modulate local variations in wall remodeling, and ultimately success or failure of the intervention. Focusing on clinically relevant vein bypass grafting as a model system, this proposal will fuel the synergy of vascular biologists, engineers, and mathematicians who will employ systems biology approaches to the complex mechanisms of vascular adaptation. This established team will construct and optimize pioneering multi-scale models to understand the interplay of micro-scale physical and biologic forces in vein graft wall behavior. The proposed hypothesis driven model conceptualizes the process of vascular adaptation as two parallel, but interconnected processes. The global remodeling response is mediated through variations in the gene regulatory network (Specific Aim 1), while the focality of lesion development is modulated through the dynamics of monocyte homing to regions of altered flow (Specific Aim 2). The general approach of this proposal is the use of robust but validated computational algorithms for the development of each module. Interfaced with extensive in vivo experimental data, each module contributes a new structural integration level to the overall model. Upon compilation, the final model will utilize an iterative loop, employing a finite element computational technique (hemodynamic module) that drives a Bayesian network (gene regulatory module) and series of partial differential equations (monocyte kinetic module), with resulting outputs interfaced through a cellular automata to predict changes in tissue architecture, which feeds back into the hemodynamic module to initiate a new cycle. Structured to maintain spatial integrity, the underlying power of the predictive model is to examine the regional difference in disease progression in a complex three- dimensional geometry. This work not only provides direct clinical translation toward improved bypass graft durability, but most importantly it stands as a powerful contemporary application of rigorous systems biology approaches to understand and treat complex medical diseases. PUBLIC HEALTH RELEVANCE: Heart attack and stroke continue to be the leading cause of mortality and morbidity in the United States. Available treatments, such as vein bypass surgery or angioplasty, currently provide only short-term improvements, and are prone to failure due to aggressive scar formation. The current proposal uses systems biology approaches to study the complex mechanisms of the vascular response to injury, providing a predictive model with application both as a research tool and in the care of patients.

Public health relevance
RELEVENCE Heart attack and stroke continue to be the leading cause of mortality and morbidity in the United States. Available treatments, such as vein bypass surgery or angioplasty, currently provide only short-term improvements, and are prone to failure due to aggressive scar formation. The current proposal uses systems biology approaches to study the complex mechanisms of the vascular response to injury, providing a predictive model with application both as a research tool and in the care of patients.